Daily personalized drinking feedback delivered via mobile phone

PROJECT SUMMARY
Many young adults engage in heavy drinking and in turn experience negative consequences (e.g., severe injury,
overdose). While personalized feedback interventions (PFIs) show promise among college students, non-
college young adults are often excluded from research, effect sizes tend to be small to medium, gains are not
usually maintained, and improvements in engagement and potential for reach are needed. Mobile technology
can be harnessed to deliver intervention, but many mHealth platforms are not theoretically based or rigorously
developed and tested. Preliminary work suggests that the morning after drinking may represent a “teachable
moment” not yet exploited for harm reduction. We propose to examine mornings after drinking as an optimal
time to provide repeated, personalized feedback with the goal of reducing hazardous drinking. Specifically, we
will further develop and pilot test a novel theory-based PFI for heavy drinking young adults. Innovations include
mobile delivery of feedback in multiple doses that occur close in time to drinking; choice of feedback; feedback
informed by daily, mobile assessment of recent key drinking events; and use of personalized and dynamic goal
setting to guide behavior change. In line with principles of the transtheoretical model (e.g., developing
discrepancy), intervention strategies include personalized feedback (e.g., prior night blood alcohol concentration,
consequences) contrasted with both drinking goals set at baseline and corrective normative feedback (e.g., how
last night’s drinking compares to peers). We have promising preliminary data on this intervention; however, prior
pilot participants included only college students. Further, they were paid for compliance with the daily surveys
that informed their feedback, but engagement in the absence of monetary reward is essential to scalability. In
the proposed study, we will incorporate end-user feedback on ways to increase engagement, and manipulate
payment in order to determine engagement with a more scalable (i.e., unpaid) daily PFI. First, a refined version
of our mobile daily PFI will be delivered in an open trial to 20 heavy drinking young adults (50% non-college).
After four weeks of daily intervention, participants will return for individual interviews to inform further refinement
of the intervention content. Finally, 132 participants (50% non-college) will be randomized to one of three groups:
PFI with monetary incentives for daily surveys, PFI without monetary incentives, or survey assessment only. We
will examine recruitment rates, retention rates, confirmation of intervention content delivery/intake, response
rates to daily surveys, data quality, and ratings of intervention value. We will test whether these indicators of
engagement differ between those who do and do not receive monetary incentives for daily surveys. Further,
baseline, post-test, and 3-month follow-up assessments will allow us to estimate effect sizes for PFI vs control
differences in drinks per week, frequency of heavy drinking, and negative consequences. The results of the
proposed research will result in a novel and scalable intervention for alcohol misuse among young adults, with
potential to have an important impact on the public health problem of high-risk drinking.

Public health relevance
PROJECT NARRATIVE Heavy drinking places young adults at risk for severe negative consequences (e.g., sexual assault, injuries), and even efficacious interventions have small and short-lived effects. The present study improves upon personalized feedback interventions by using mobile-delivery to provide repeated event-specific personalized feedback delivered close in time to drinking events. This research has the potential to have a major impact on public health by reducing high risk drinking and consequences among young adults, both college and non- college.